EFFECTS OF ERYTHROPOIETIN ON TRANSFUSIONS FOR VERY LOW BIRTH WT INFANTS

This study's aim is to determine if the administration of Epo to extremely low birth weight infants will increase reticulocyte counts and hematocrits, and a decrease in their transfusion requirements during the first three weeks of life in a cost-effective fashion.